BASIC AIDS RELATED IMMUNOLOGY RESEARCH

The goal of this project is to study the regulation of dendritic cells (DCs) and immunodeficiency viruses. The year 1997 was very productive in our lab and resulted in a number of publications. We found that human immunodeficiency virus type I (HIV-1), like simian immunodeficiency virus, requires signaling of CD28 or IL-2 receptors in order to replicate in resting T cells and move to the nucleus to form LTR circles, i.e., set up a latent infection. This finding suggests that selective blockade of certain T cell signaling pathways may reduce virus load in HIV-infected individuals. We developed a method and model for isolating and characterizing macaque DCs and found that we can infect macaque DCs in vitro with HIV-2. We have isolated human blood DCs and found that CD4 ligation signals survival in DCs and makes them more effective antigen-presenting cells. We have also defined a set of genes that are induced after CD40 ligation of immature DCs, including the death receptor, TRAIL, and death caspase, caspase-7. A major effort will continue to be the definition of DC signaling pathways and discovery of how they are affected by HIVs. We reported a role for c-myc in B cell receptor induced death. A novel receptor that we helped to discover was given a new CD number, CDw150. Significant effort was spent on the preparation of review articles on DCs and their role in HIV pathogenesis and a chapter on the mechanisms of cellular cooperation to be published in an encyclopedia of immunology.